Improving long-term allograft survival in kidney transplantation by targeting B cell survival cytokines

PROJECT SUMMARY/ABSTRACT
The proposal presents a four-year career development program designed to provide Sarah Panzer, MD, an
Assistant Professor at the University of Wisconsin-Madison, the career development and research experiences
necessary to become an independent physician scientist to improve patient and allograft survival of kidney
transplant recipients. Approximately 50% of transplanted kidneys fail within 10 years of transplantation. The
major pathologic diagnosis in failing kidney allografts is transplant glomerulopathy (TG). While TG has largely
been attributed to chronic antibody-mediated rejection (cABMR), the key mediators of this process remain
unknown and no effective therapeutics exist. In a multitude of B cell mediated diseases, the B cell survival
cytokines have been demonstrated to exacerbate disease activity and represent a viable therapeutic target. In
kidney transplantation, preliminary studies have found elevated levels of B cell survival cytokines in the serum
and kidney tissue of patients with cABMR. The hypothesis of this proposal is B cell survival cytokines play
pivotal roles in promoting the development of TG and predict allograft failure. This proposal will test this
hypothesis via 1) deficiency of B cell cytokines in an animal kidney transplant model to attenuate TG, 2)
determination of the ability of intragraft B cell cytokines to predict allograft failure in prevalent TG patients, and
3) determination of B cell survival cytokines as a risk factor for incident TG in a prospective observational
cohort of high-risk kidney transplant patients. These data will support future R01 funded study to investigate B
cell survival cytokines in TG as a therapeutic target. As a junior faculty member at an institution with extensive
infrastructure to support early stage investigators and a highly active transplant center, Dr. Panzer is in an ideal
environment to complete the proposed research and pursue advanced training. Her career development plan
includes both coursework and mentored research training in the areas of clinical study design, subject
recruitment and retention, and survival analysis. To ensure success, she has identified committed, expert
mentors and secured protected time for this work. This award addresses a significant gap in the field of kidney
transplantation while affording the mentored research experience critical for Dr. Panzer to become a
successful physician scientist leading a program to improve outcomes in kidney transplantation.

Public health relevance
PROJECT NARRATIVE Many kidney transplant patients with chronic rejection develop transplant glomerulopathy (TG) and are at high risk of failure of their kidney transplant. The proposed work will test the impact of depleting B cell survival cytokines in a kidney transplant model and determining if B cell survival cytokines are a risk factor for kidney transplant failure in patients. Currently, there are no effective treatments for TG; the long-term goal is to apply the research findings in future clinical studies to test therapeutics targeted at B cell survival cytokines to improve long-term kidney transplant survival.